TRIAL OF NIMODIPHINE FOR NEUROLOGICAL MANIFESTATIONS

This treatment study is aimed at improving the dementia associated with HIV infection. Experiment evidence indicates that the calcium channel blocker, nimodipine, prevents cytotoxic effects of HIV-1 on neurones in cell cultures by inhibiting the calcium influx into the neurones. Our hypothesis is that a similar mechanism may operate in HIV dementia and may be similarly interrupted by nimodipine.